Elucidating the sequence code for amyloid peptide self-assembly through all-atom simulations, machine learning, and experiments

ABSTRACT
Extensive efforts are being dedicated to design β-sheet nanofibrils by amyloid-inspired peptides as they exhibit
mechanical properties that are desirable for various biomedical applications. These efforts require tools that are
accurate at predicting the propensity of a peptide to form fibrils from its amino acid sequence. Moreover, they
must consider that deposits of amyloid fibrils in different tissues and organs are emblematic of diseases like
Alzheimer’s and Parkinson’s. Accordingly, engineered non-toxic amyloids are expected to show a low degree of
homology compared to diseases-causing amyloids. Existing bioinformatic tools, which are informed by disease-
causing amyloid, are often not suitable to describe this class of peptides. This project combines all-atom
molecular dynamics (MD) simulations, machine learning, and experiments, to develop and validate an approach
that will be accessible, accurate, and efficient at predicting fibril formation for any peptide sequence.
This project expands on recent studies showing that the combination of faster computers and more accurate
force fields are now allowing all-atom molecular dynamics to simulate the spontaneous formation of amyloid
fibrils from unbiased initial conditions. These studies have been used to identify intermediate states on pathway
to fibril formation as well as describe the mechanisms allowing peptides to lock onto the fibril tip with atomic
precision accounting for its growth. In addition, for a limited set of designed peptides, all-atom simulations
showed more accurate propensities to form fibrils than bioinformatic tools highlighting its predictive potential.
However, simulations remain computationally intensive requiring several weeks to be completed. Thus, they
cannot be used for a high throughput investigation of sequences required in efforts to design peptides for
biomedical applications. This project addresses this knowledge gap and expands the scope of all-atom
simulations to peptides that form complex fibrils that resemble more closely the ones from disease-causing
amyloids. Moreover, undergraduate students are involved in all aspects of this project including managing,
setting up, and running MD simulations. The three aims of the project are:
Aim 1 of this project develops machine learning algorithms to predict in a few seconds if a peptide will self-
assemble into amyloid fibrils in MD simulations. These predictions will be validated and tested experimentally to
establish the scope of application of different MD force fields. Aim 2 of this project performs a high throughput
analysis of the sequence space to determine peptides that form fibrils and discover rules in the amino acid
sequence that encode for these structures. Aim 3 of this project expands the use of unbiased all-atom
simulations to study peptides that form complex fibrils characterized by parallel β-sheets connected to each other
via β-arcs. The molecular mechanisms and pathways accounting for these fibrils will be investigated and will be
used to provide insight into disease causing amyloids.

Public health relevance
The proposed research develops in silico tools to elucidate the amino acid code of peptide self- assembly related to amyloid diseases and engineered non-toxic amyloids. Moreover, it expands the use of computer simulation to proteins that more closely resemble disease-associated amyloids. This is critical to provide insights to new treatments for diseases like Alzheimer’s and Parkinson’s.